Pilot Projects Program

The Pilot Projects Core
The overall objective of the Pilot Project Core in Phase III is to sustain the research environment developed in
the first two phases by providing support for pilot research projects, career guidance, and enhancement activities.
As part of the Administrative Core in prior phases, we have awarded 25 investigators with 29 pilot projects from
multiple disciplines. These Pilot Project awardees, guided by experienced mentors, have developed new
research collaborations, published 280 manuscripts, received 93 independent extramural awards with a total
amount over $33.9 million, served as mentor for over 170 trainees, and presented at 343 invited sessions,
including 47 international, 100 national, and 196 local venues. Building on our past success, the Pilot Project
Core in Phase III, along with support from the Administrative Core, is poised to meet the needs of the Pilot Project
Investigators in the area of CPVB with professional development activities and pilot funding to test out new,
novel, innovative ideas, obtain preliminary data for grant submissions, develop techniques or scientific
approaches, and establish new collaborations. Moreover, our pool of potential pilot project applicants remains
strong and is anticipated to grow with key faculty recruitment in cardiovascular and pulmonary divisions ongoing
at Ocean State Research Institute/Providence VA Medical Center and at our affiliated hospitals and universities.
Congruent with the overarching goals of CPVB COBRE, the Specific Aims of the Pilot Projects Core are to: i)
award high-impact pilot projects in area of cardiopulmonary vascular biology; ii) promote professional
development and extramural funding of early career faculty pilot project awardees through structured
programming, mentorship, and exposure to leaders in the field; iii) facilitate new collaborations and research
teams through prioritization of interdisciplinary, interinstitutional, and bench to bedside collaborations; and iv)
enhance the user base for technical core services and leverage stakeholders to sustain pilot funding in CPVB.
Availability of the CPVB COBRE supported Pilot Project funding over the next 5 years, coupled with the CPVB
COBRE technical core expertise and services and professional development activities, will be critical to retain
early career faculty and faculty focused on vascular biology in RI.